Phthalates and Phthalate Alternatives and Early Human Cardiometabolic Development

PROJECT SUMMARY/ABSTRACT
Phthalates are ubiquitous environmental endocrine-disrupting chemicals with a wide range of potential adverse
health effects. Laboratory studies have identified developmental effects of phthalates on cardiovascular and
adipose formation and growth, contributing to adverse cardiometabolic outcomes across the lifecourse. Human
studies have only recently been able to noninvasively assess fetal cardiovascular and adipose development,
and few studies have prospectively evaluated cardiometabolic outcomes following prenatal phthalate
exposure. In the HPP-3D Study, 90% of pregnancies were exposed to phthalates and new chemicals used to
replace phthalates (alternatives), highlighting the critical need for human studies to better understand the
impact of these chemicals on cardiometabolic health. The overarching objective of this proposal is to
investigate associations between prenatal phthalates and phthalate alternatives and fetal (Aims 1 and 2) and
pediatric (Aim 3) cardiometabolic outcomes in the HPP-3D Study. With up to eight exposure assessment
timepoints, this study has one of the most comprehensive characterizations of prenatal nonpersistent
environmental chemical exposures to date. Utilizing innovative tools to repeatedly assess fetal cardiovascular
outcomes and body composition, I will provide novel insight into associations between these well-characterized
exposures and longitudinal fetal cardiometabolic development in the K99 phase. Building on this rich resource,
I will employ a two-pronged approach to conduct follow-up of HPP-3D Study children in the R00 phase using
electronic medial records (Aim 3a) and advanced cardiometabolic assessments during an in-person clinic visit
on a subset of 40 children (Aim 3b). The proposal will incorporate innovative environmental mixture methods
and will examine periods of susceptibility across pregnancy to appropriately quantify the human exposure
experience, identify biological mechanisms, and improve targeting of future exposure investigations and
interventions. With the majority of American youth having at least one cardiometabolic abnormality, there is a
critical need to identify intervenable risk factors for adverse cardiometabolic development. This research will
therefore provide crucial insights into the effect of endocrine-disrupting phthalates and phthalate alternatives
on human cardiometabolic development, which will have implications for the etiology and prevention of
cardiometabolic dysfunction. To be successful in the proposed work and launch my independent research
career, I will build on my strong prior epidemiologic training with experiential and didactic professional
development trainings in environmental and cardiovascular assessments and the conduct of clinical research.
This training will take place within the interdisciplinary environment of the Intramural Research Program at the
National Institute of Environmental Health Sciences with the support and mentoring of highly accomplished
epidemiologists and physician-scientists. This career development award will launch my independent research
career investigating the impact of environmental exposures on early cardiometabolic health.

Public health relevance
PROJECT NARRATIVE Pregnant women are highly exposed to phthalates and phthalate alternatives in consumer and personal care products, but the short- and long-term developmental effects of this ubiquitous exposure in humans is not well- understood. This project uses data from a prospective pregnancy cohort to determine the individual and joint effects of phthalates and phthalate alternatives on human cardiovascular and adipose development in early life. This study will significantly advance our understanding of the adverse cardiometabolic effects of phthalates and their alternatives, informing timeframes and strategies for improvement of short- and long-term cardiometabolic health.